Comparative Safety of Pain Medications

Project Summary
Clinicians, patients, and researchers encounter numerous challenges in their efforts to treat chronic pain
effectively and safely. Chronic pain affects approximately 1 out of 3 Americans and costs up to $635 billion a
year for treatment and lost productivity; the excessive prescription of opioids has escalated into a crisis. Non-
opioid pain medications are one alternative treatment method for pain management; however, data on these
medications are limited to clinical studies that lacked the power to evaluate safety outcomes appropriately.
Despite the crucial role of clinical trials in establishing treatments’ efficacy, many drugs have had unforeseen
and serious long-term side effects. Pharmacoepidemiologic studies offer the opportunity to study these risks,
particularly among vulnerable populations often excluded from clinical trials. We propose three such studies
aimed to provide critical information about the cardiovascular risks associated with the use of three widely
prescribed non-opioid medications used to treat patients with chronic pain: cyclobenzaprine (muscle relaxant),
duloxetine (serotonin-norepinephrine reuptake inhibitor), and pregabalin (analgesic anticonvulsant). We selected
these drugs for the following reasons: 1) they are used by millions of patients; 2) multiple case reports raise
concern for increased risk of serious cardiovascular events; and 3) their mechanisms of action raise significant
concern about cardiovascular toxicity. More specifically, cyclobenzaprine is structurally similar to amitriptyline, a
drug widely-recognized to be cardiotoxic; duloxetine raises adrenergic activity, which potentially increases the
risk of myocardial infarction. Pregabalin causes significant fluid retention, and thus can exacerbate heart failure.
Consequently, there is an immense need to define these drugs’ risks, specifically serious cardiovascular
outcomes resulting in hospitalization or death.
We propose to study Medicare Part D beneficiaries because their increased risks and multiple comorbidities
heighten the potential for cardiovascular side effects. With increasing scrutiny and limitations placed on opioid
prescriptions (one in three beneficiaries received at least one opioid prescription in 2016), the number of
Medicare beneficiaries filling prescriptions for these non-opioid drugs—already in the millions—is likely to
increase, despite the lack of high quality long-term safety data.
We will use state of the art pharmacoepidemiologic techniques and a large database of Medicare enrollees to
assemble a cohort of patients with chronic non-cancer pain. Aim 1 will define the risk for serious cardiovascular
outcomes in patients taking cyclobenzaprine. Aim 2 will define the risk of serious cardiovascular events
associated with the use of duloxetine. Aim 3 will define the risk of heart failure associated with patients taking
pregabalin. These studies will compare those risks with the risk observed in patients with chronic pain taking
gabapentin, an anticonvulsant with no clinical signals of cardiovascular side effects.

Public health relevance
Relevance We are currently in the midst of a chronic pain crisis, and increasingly, prescribers are encouraged to offer non-opioid alternatives. This proposal addresses three such medications, whose mechanisms of action suggest the potential for cardiovascular events. These drugs are already used by millions of Americans each year, and as their use escalates, it behooves us to better understand and advise patients about their related risks.